Genetic basis of metabolite production against clinically-derived pathogens

Mortality from multi-drug resistant (MDR) bacterial infections is projected to cause 10 million deaths per year
worldwide by 2050, making antibiotic resistance a vital threat to society. Fueling this crisis even further is the
increased use of antibiotics among 45-97% of COVID-19 patients, which will likely boost selective pressure for
MDR phenotypes. Unfortunately, with the misuse and overuse of these chemical compounds, pathogens have
evolved several mechanisms to resist all currently used anti-infective agents. The World Health Organization
recently deemed carbapenem resistant Pseudomonas aeruginosa as one of the most difficult infections to treat,
so future management of this species and other Gram-negative pathogens will require novel, yet undiscovered,
antibiotics. As a bacterial group, environemtnal Pseudomonas strains (env-Ps) are well known for their extensive
genomic content and diversity. Owed to their genetic complexity is the production of an assorted repertoire of
secondary metabolites that have been shown to prevent the growth of pathogenic fungi, breakdown complex
recalcitrant compounds, exhibit anti-tumor activity, and inhibit a wide range of bacterial pathogens including
methicillin-resistant Staphylococcus aureus and Mycobacterium tuberculosis. Moreover, soil and freshwater
environments are dominated worldwide by pseudomonads, whose global abundance suggest the expression of
certain traits that are advantageous to ecological survival. In contrast, P. aeruginosa is observed infrequently in
ecological settings. One trait that is likely to contribute to such fitness effects of env-Ps is the ability to antagonize
nearby competitors through production of antimicrobial compounds. Previous work showed that water-derived
env-Ps were able to inhibit cystic fibrosis (CF) derived pathogens including P. aeruginosa, Burkholderia,
Achromobacter, and Stenotrophomonas species, and subsequently identified gene clusters involved in
antagonistic activity within the environmental strains. As a continuation of this project, env-Ps from nutrient-rich
water systems are hypothesized to be sources of potent antimicrobial activity. Indeed, preliminary data shows
that env-Ps from a polluted river exhibited the remarkable ability to inhibit CF-derived extensively drug resistant
(XDR) pathogens, including carbapenem resistant P. aeruginosa. In this study, an innovation approach using
culturable bacteria will be utilized to link antagonistic activity (phenotype) to diverse biosynthetic gene clusters
(genotype) involved in antimicrobial activity. By investigating direct competitive interactions between env-Ps and
XDR pathogens, novel antagonistic factors are expected to be identified. This will be achieved by (i) isolating
and determining the antimicrobial activity of env-Ps from polluted water columns; (ii) identification of biosynthetic
gene clusters involved in the activity; and (iii) initial characterization of encoded undiscovered compounds.
Combined results will be used to identify metrics that select for potent antagonistic strains for the future of
targeted novel antimicrobial compound discovery.

Public health relevance
The proposed research will focus on the discovery of new antibiotics from environmental bacteria that are effective against drug resistant pathogens. Results will include the identification of genes and encoded product involved in activity. This work has potential to impact human health through the development of new antimicrobial compounds.